Short-Term Training Program to Increase Diversity in Health-Related Research

Project Summary
The goal of this short-term research training program is to utilize research training opportunities
in the areas of cardiovascular, pulmonary, hematologic, and sleep disorders to increase the
readiness and competitiveness of students traditionally underrepresented in these areas as they
train for and enter careers in the biomedical research workforce. The limited pool of qualified UR
groups applying to graduate programs points to a clear need for focused mentorship and
training for students from UR groups as they prepare for graduate training. To address this
need, Brown University requests a competitive renewal of NIH NHLBI funding for the
Short-Term Training Program to Increase Diversity in Health-Related Research to permit 17 UR
undergraduate students per year to participate in an intensive 9-week summer research training
experience with exposure to multidisciplinary research directly related to cardiovascular,
pulmonary, hematologic, and sleep disorders.
This will be achieved by creating immersive learning environments inside and outside
the lab. Selected students are paired with faculty sponsors for training in the lab and interact
with peer and faculty mentors in other academic settings. The specific aims of this program
are:
a) Enhance the scientific education and research skills of its participants;
b) Instill self-affirming practices in participants of this program who, in turn, will model this
success to their peers;
c) Initiate the process by which participants become life-long learners by helping them to
develop the skills and habits of scientists and scholars;
d) New Initiative: Foster a continuity of mentorship and training to support the progression
of underrepresented students along PhD and MD-PhD training pathways and into the
biomedical workforce;
e) New Initiative: Expose underrepresented students to research and role models to
increase their competitiveness for PhD or MD-PhD training programs.
This project builds on our previous successes and fortifies efforts to increase the ranks of
underrepresented scholars in doctoral programs and the scientific workforce.

Public health relevance
Project Narrative This project will address the need to improve domestic scientific excellence so as to ensure that the U.S. is able to engage in scientific practices that are consistent with our future needs in the areas of biomedical research, healthcare advances and education by providing training to undergraduate college students who are racial and ethnic minorities, disabled individuals and socioeconomically disadvantaged individuals. The project will i) implement strategies that strengthen education and address student needs, which impact their retention and interests leading to biomedical careers; ii) work to keep student trainees on a trajectory that will help them seamlessly transition from the undergraduate career stage to more advanced stages; and iii) instill self confidence that leads to success, which they will model for future students considering similar career pursuits, and provide opportunities for long-term mentoring to ensure achievement of their career goals.